Plasmodium and Anopheles midgut interactive proteins influence malaria transmission

SUMMARY
Malaria caused by Plasmodium parasites affects millions of people worldwide. The life cycle of the malaria
parasites involves a vertebrate host and mosquito vector. Transmission through Anopheles mosquitoes is an
obligatory step of the parasite’s life cycle and represents a vulnerable target for transmission-blocking strategies.
After the ingestion of Plasmodium-infected blood, the parasites inside the mosquito’s midgut undergo
gametogenesis and fertilization, and the resultant zygote transforms into a motile ookinete. Within about 24 hours,
the ookinete must escape the blood bolus, penetrate the midgut peritrophic matrix and epithelium, and eventually
lie beneath the basal lamina for sporogonic development. Despite the significance of midgut invasion for the
successful transmission of the parasite, the molecular mechanisms of the invasion process are poorly
understood. We hypothesize that the parasite-mosquito midgut interactive proteins serve essential roles in
parasite invasion in mosquitoes and that disrupting these interactions will stop malaria transmission. To better
understand the parasite invasion process in the midgut, we have performed large-scale screening of a midgut
protein library and a parasite sexual-stage protein library and identified candidate proteins from each library that
potentially mediate the parasite-midgut interactions. Based on these discoveries, this proposed research will
study the molecular mechanisms of parasite-midgut interactions and evaluate these protein candidates as novel
targets for transmission-blocking vaccines. We will functionally characterize these mosquito and parasite
proteins to study their tissue distribution and subcellular localization and identify their binding partners. We will
also determine their transmission-blocking potential using in vitro mosquito feeding assays and map the essential
epitopes using a panel of monoclonal antibodies. Finally, we will design chimeric antigens that target both the
parasite and mosquito antigens to achieve stronger transmission-blocking activities. The long-term goal of this
project is to gain a significant understanding of the mechanisms of parasite-mosquito midgut interactions and
develop new approaches to stop malaria transmission.

Public health relevance
PROJECT NARRATIVE More than 200 million malaria cases and approximately half a million deaths occur worldwide each year. Malaria transmission through mosquitoes is an obligatory process of the Plasmodium parasite life cycle. This project will investigate the proteins that mediate interactions between the malaria parasite and mosquito midgut and assess their potential as novel vaccine targets for blocking malaria transmission.